Alzheimer's Disease Neuroimaging Initiative (ADNI4)

Overall: Summary/Abstract
The overall goal of ADNI is to validate biomarkers for AD clinical trials. ADNI data is widely used for planning AD
trials and use of ADNI data has enabled dramatic changes to trial design, including early intervention strategies.
ADNI data was used to design the aducanumab (Aduhlem™) trials leading to FDA approval. We have widely
shared clinical/cognitive, imaging, and biomarker data and provided genetic, CSF, and plasma samples to the
scientific community leading to over 3600 publications, providing major contributions to the overall knowledge of
AD progression and pathophysiology. ADNI4 directly addresses two critical developments in field: incorporation
of plasma biomarkers and enhancing recruitment of underrepresented populations (URPs). To address concerns
about lack of generalizability, we created the Diversity Task Force which increased enrollment of URPs in ADNI3.
This led to the creation of the Engagement Core which will focus on URP recruitment. Our goals are: first, to
continue to validate biomarkers for AD clinical trials, and second, to recruit a more diverse participant population
to create and share more generalizable data concerning the relationship of biomarkers and pathology to cognitive
decline and dementia. This will be accomplished by: 1) Maintaining and widely sharing the digital data, biofluid,
genetic and neuropathology repositories; 2) Following ~500 rollover participants from ADNI3, with priority for
symptomatic and URP participants; 3) Greatly increasing recruitment of new URPs using a community-engaged
approach employing “boots on the ground” recruiters, and navigators to provide digital/telephone support.
Additionally, a digital marketing campaign targeted at URPs will screen and longitudinally assess 20,000
participants and identify 4000 (50-60% URPs) for blood collection at Quest Diagnostics phlebotomy centers.
Plasma for A 42/40 and phospho-tau, will identify those AD biomarker+ (e.g., amyloid+). We will relax inclusion
criteria to allow more comorbidities than in previous ADNI cohorts and thereby increase the prevalence of mixed
dementias and cerebrovascular disease. This will facilitate enrollment of ~500 new participants (50-60% URPs,
overall 80% amyloid +, 40% cognitively unimpaired, 40% MCI, 20% dementia) into the ADNI in-clinic battery
(clinical assessment, MRI, PET, CSF, plasma). Thus, ~1000 participants will be enrolled into the in-clinic portion
of ADNI4. The remaining 3500 participants will be followed longitudinally with follow-up blood testing. The MRI
Core will add new sequences for cerebrovascular disease and improve harmonization. The PET Core will add
new amyloid and tau PET tracers. Project 1 will optimize diagnosis of AD, monitoring change, and compare
imaging and plasma biomarkers. In summary, we will recruit a diverse population for multisite clinical trials,
demonstrating the feasibility of digital and blood test screening and monitoring participants on treatments. ADNI4
will guide future AD clinical trials and provide longitudinal clinical, biomarker and autopsy data collected since
2004 to investigators worldwide.

Public health relevance
The Alzheimer’s Disease Neuroimaging Initiative (ADNI) is a large multisite public private partnership that validates brain imaging, blood tests, and other diagnostics, sharing all data with the scientific community, resulting in over 3600 publications with a major impact on clinical research and the development of methods for clinical trials. In this phase of ADNI we will enhance the generalizability of our results to the entire US population, by enrolling a substantial proportion of our new participants from groups previously underrepresented in research, using plasma measurement of AD biomarkers with local phlebotomy centers, a community engagement approach and digital assessments, while continuing and expanding our previous work with MRI and PET scanning. This initiative will greatly facilitate design of clinical treatment trials and will help develop new diagnostic techniques, which identify AD at an early stage, leading to more effective treatment and prevention of AD.